Optimizing CBT Implementation among Community Providers Through Internet-based Consultation and Networking (i-CAN)

PROJECT SUMMARY
The goal of this exploratory/developmental (R21) project is to advance the uptake of cognitive-
behavioral therapy (CBT), an evidence-based intervention (EBI) for youth anxiety problems, by
community-based providers. Using readily available, commercial-grade software, we will
develop a highly replicable remote (online) peer consultation and support hub. This hub, termed
Internet-based Consultation and Networking [i-CAN], will be developed with input from
stakeholders, including community providers, using a participatory implementation workgroup
approach. We will then test the feasibility and preliminary impact of i-CAN in the context of a
pilot randomized controlled trial with a diverse sample of providers. The purpose of program
announcement PAR-19-275 is to “support innovative approaches to identifying, understanding,
and developing strategies for overcoming barriers to the adoption…of evidence-based
interventions.” Although clinical anxiety is one of the most impairing and common mental health
problems seen among children and adolescents1, and CBT is considered an established EBI for
anxiety disorders2, most youth do not receive high-quality CBT in their home communities. This
implementation gap is especially prominent for youth who live in rural areas, communities of
color, and low-resources settings.3–5 We are testing i-CAN in a large community that is
characterized by rurality and poverty, and which is highly racially diverse, because remote peer
consultation may be especially beneficial for providers who cannot otherwise access in-person
support to improve their skills. As such, this project addresses disparities by improving access
to EBI resources and tools among the providers who work in under-served communities. In
addition to high

Public health relevance
PROJECT NARRATIVE There is a gap of nearly 20 years separating the production of research establishing evidence- based interventions (EBI) and the use of those EBIs in communities. By developing an easy-to use online support and peer consultation hub, we hope to decrease this gap by improving dissemination and use of EBI for childhood anxiety, especially within diverse and under-served client groups. The long-term goal is that this platform can be used widely used and expanded to multiple forms of EBI.